Core A: Islet Cell Biology Core

The Islet Cell Biology Core provides services and hands-on training to independently funded investigators in the isolation and functional characterization of pancreatic islets from normal and diabetic humans and mice. It also maintains a repository of insulinoma cell lines as well as other endocrine cell lines. The primary emphasis of the Core is to facilitate studies of primary islet cells, and it has developed many unique tools and techniques for carrying such studies including novel animals models, biophysical methods and a library of adenovirus-based expression constructs for studying beta-cell function. The long-range objectives and goals of the Islet Cell Biology Core are to provide state-of-the-art technology and know-how to understanding the beta cell in health and disease. It has the following Specific Aims and Objectives: Provide advice, service and training in the isolation of pancreatic islets from normal and diabetic mice and humans; Provide insulinoma and other endocrine cell lines; Provide advice, service and training in the characterization of mouse and human pancreatic islets and beta cell (insulin biosynthesis and secretion; biophysical methods for studying islet and beta-cell function (e.g. calcium imaging, electrophysiology, total internal reflection fluorescent microscopy); biochemical methods for studying beta-cell function (e.g. phosphorylation, proliferation, apoptosis); and immunohistochemical analysis of pancreatic islets) and Provide advice, service and training on the use of adenovirus-based expression constructs to study protein function in beta cells and other cell types in vitro and in vivo. Drs. Philipson, Rhodes and Witkowski are Directors of this Core. They will be advised by experts in pancreatic islets and beta cells (Prince and Steiner), cellular and physiological imaging (Bindokas, Chen and Glick), ion channels (Hanck and Nelson), spectroscopy (Halpern and Scherer) and cell dynamics (Dinner) to ensure that the Core services are at the forefront of technology and thus able to anticipate and quickly repond to users needs.

Public health relevance
RELEVANCE (See instructions): The Islet Cell Biology Core provides advice, services and hands-on training in the isolation of pancreatic islets and studies of their function. It provides a foundation for studies of beta cell and islet biology that are fundamental to understanding the pathophysiology of diabetes.